Sustaining Innovative Tools to Expand Youth-Friendly HIV Self-Testing (S-ITEST)

Many adolescents and young adults (AYA, 14-24 years old) in Nigeria have a substantial HIV risk but do not
receive HIV prevention services. While pre-exposure prophylaxis (PrEP), HIV self-testing, sexually transmitted
infection (STI) testing, and linkage to AYA-friendly clinical services are essential, they have not been widely
implemented or sustained in Nigeria. This underlines the importance of implementation science to increase the
adoption and maintenance of HIV prevention services for AYA in diverse settings. Our 4 Youth by Youth
(4YBY) program (NICHD UH3HD096929) leveraged participatory implementation strategies like crowdsourcing
open calls and designathons and participatory learning communities to develop AYA-led PrEP uptake, HIV
self-testing, and STI testing services in Nigeria. The success of this NICHD-funded Prevention and Treatment
through a Comprehensive Care Continuum for HIV-affected Adolescents in Resource Constrained Settings
Implementation (PATC3H) pilot program facilitated transition to an NICHD U-supported randomized controlled
trial underway in 32 local government areas. Interim data demonstrates that the 4YBY program is effective, but
how to transition this research study into practice and sustain it overtime for AYA in Nigeria requires further
investigation. As a multi-disciplinary research team with proven track record, we propose the following specific
aims: (1) To use participatory approaches with Nigerian youth (i.e. crowdsourcing designathons and
participatory learning communities) to develop new strategies for sustaining the 4YBY program; (2) To
evaluate the effectiveness of a finalist sustainment strategy to sustain core elements of the 4YBY program
among at-risk, HIV-negative AYA (14-24 years old) in Nigeria using a cluster randomized control trial in 32 new
local areas; (3) To estimate the impact and cost-effectiveness of the overall 4YBY program. We define
sustainment based on the continuation of core elements of the 4YBY program at sufficient fidelity, the
continuation of intended benefits, and adequate capacity for the continuation of the program. The Youth
Participatory Action Research framework and the PEN-3 cultural model will inform our study. Implementation
science aspects will be guided by the Proctor’s Implementation Outcomes Framework and the Consolidated
Framework for Implementation Research (CFIR). We will also estimate the cost of implementing and
sustaining the 4YBY program. We are currently implementing 4YBY in 32 local areas among a general
population of AYA for 24 months. Within this cohort, we will integrate the final sustainment strategy and collect
data on sustainment over time. In addition, we will recruit 32 new local areas with higher risk (PrEP-eligible)
AYA that will either receive the same sustainment strategy alongside 4YBY (16 areas) or a standard 4YBY
program (16 areas). Findings from the proposed S-ITEST (Sustaining Innovative Tools to Expand HIV Self-
testing) study will be relevant in other settings. S-ITEST responds to high-priority topics identified by the United
States National Institutes of Health, NICHD, NIMH, FIC, and OBSSR.

Public health relevance
PUBLIC HEALTH RELEVANCE This study will enhance essential HIV prevention services and increase our understanding of how to sustain critical HIV prevention services over time in Nigeria. The project draws on the unique strengths of Nigerian youth to develop youth-inspired sustainment strategies and evaluate how to sustain components of the 4 Youth By Youth (4YBY) program for HIV uninfected at-risk youth. This study will help inform the sustainment of HIV prevention strategies that reduce the acquisition of HIV in at-risk youth living in resource constrained settings in low- and middle-income countries (LMICs).